Introduction of STEM Food Safety Careers to the Underrepresented

Abstract Title: Introduction of STEM Food Safety Careers to the Underrepresented
Authors: Rochelle Olaleye, SO; Frederick Olaleye, PI
FDA Strategic Initiative: ORA has a commitment to diversity and an ongoing need for qualified
individuals with backgrounds in health-related sciences, regulatory policy, and information technology
Abstract:
Synopsis
The U.S. Bureau of Labor Statistics projects food safety employment will rise eight percent by 2026. The global
food industry is currently a five trillion-dollar market and employs millions of people worldwide. By 2050, it’s
expected that the global population will grow to 9.6 billion, putting increased pressure on the food industry to
supply safe and authentic food. A significant increase in skilled workers is needed across the globe.
Purpose
o To introduce underrepresented STEM students to food safety and manufacturing careers in government
agencies, nonprofit organizations and private industries. STEM food careers include ensuring products are
safe, wholesome, correctly labeled. Our goals are to introduce underrepresented STEM students to food safety
career personnel and potential student internships/fellowships in food safety careers.
Methods
o We have planned and implemented conferences to educate attendees, connect partners and participants
and develop and grow ecosystems. The U.S. Bureau of Labor Statistics projects that food safety employment
will rise eight percent by 2026. As many as 2.1 million manufacturing jobs will be unfilled through 2030,
according to a study published by Deloitte and The Manufacturing Institute. The report warns the worker
shortage will hurt revenue, production and could ultimately cost the US economy up to $1 trillion by 2030. This
career conference serves to introduce food safety and food science companies to qualified candidates from
underrepresented populations.
Results
o By introducing new candidate pools, and diverse qualified students to new career opportunities in food
science and food safety, we increase the possibilities of diversity in thought and approach to supplying good
food to the world markets.
Implications
o Identifying knowledgeable, skilled workers and leaders in the food industry to supply safe and authentic food
to people across the globe is key in sustaining healthy food shifting the focus from responding to foodborne
illness to preventing it, as directed in The FDA Food Safety Modernization Act (FSMA).

Public health relevance
Rochelle Ola Consulting, LLC PAR-19-306 Project Narrative Introduction of STEM Food Safety and Food Science Careers to the Underrepresented Underrepresented STEM students will participate in an in person and virtual food safety and food science careers symposium during the Food Safety and Food Science Career Conference. The conference will feature speaker sessions, provide face to face opportunities for in person discussions, and an exhibition hall where food and beverage companies will meet students, provide information on their company, internships and career opportunities. The conference targets informing and building a diverse pipeline of qualified candidates from underrepresented communities.